Early life influenza infection and glial dysregulation

SUMMARY
Millions of children in the United States contract respiratory infections such as influenza, RSV, and COVID-19
every year, with those under the age of five affected the most severely1,2. Respiratory infections can have long-
term effects on the central nervous system in both adults and children3–11. In fact, currently, 6 million children are
suffering from long COVID, and up to 44% of these children experience cognitive impairment3. Childhood is a
critical period for synaptic formation and myelination, making the brain particularly vulnerable to insults that can
lead to permanent and long-lasting neurocognitive changes12. In rodents, postnatal day (P)14 is a crucial period
of peak synaptogenesis and myelination12–14. As a result, during this time, a respiratory immune challenge such
as influenza can result in persistent neurodevelopmental dysfunction. While many studies have investigated the
neurological effects of systemic immune challenges during the prenatal and adult periods15–18, the impact of
influenza infection during early postnatal life remains understudied. The proposed study aims to investigate the
effect of influenza infection at P14 on glial dysregulation in mice. The overarching hypothesis is that influenza
infection results in multicellular dysfunction driven by aberrant microglia. My preliminary data show that influenza
infection at P14 leads to an increase in reactive microglia one-week post-infection in the cingulum and dentate
gyrus, along with elevated expression of inflammatory genes in microglia as revealed by single-nuclei RNA
sequencing. I will employ advanced transcriptomic analysis to examine changes in glial sub-states, and to
identify alterations in synapse/pruning-associated genes (Aim 1A). Additionally, changes in microglia-mediated
synaptic pruning will be assessed using Imaris 3D reconstructions to quantify microglial engulfment of synapses
following infection. My preliminary findings indicate that influenza infection results in a decrease in OPCs and
oligodendrocytes in the cingulum and dentate gyrus one-week post-infection. I will use an established
optogenetics paradigm19,20 to stimulate excitatory dentate gyrus neurons and test for changes in activity-
dependent myelination following infection (Aim 2). Finally, based on the hypothesis that reactive microglia
dysregulate oligodendroglial dynamics, microglia will be depleted between P7-P21 to determine if this rescues
the observed loss of oligodendroglial cells (Aim 3). Given my experiences investigating the impact of prenatal
environmental immune challenges on microglia and behavior, I am well-prepared to execute these experiments.
This work will be conducted under the sponsorship of Michelle Monje, MD/PhD, a leading expert in glial-neuron
interactions and myelin plasticity. The co-sponsorship of Catherine Blish, MD/PhD, will ensure comprehensive
guidance on virologic aspects, and collaborations with Karl Deisseroth, MD/PhD, Akiko Iwasaki, PhD, and Beth
Stevens, PhD, will provide the necessary support to successfully achieve the aims of this project. Stanford's
rigorous training environment and the collective support from these experts will ensure the project's success and
my growth into an innovative physician-scientist capable of developing therapies for neuroimmune diseases.

Public health relevance
PROJECT NARRATIVE Each year, millions of children in the United States contract influenza, and while these viruses primarily infect the respiratory tract, they can also affect the central nervous system. Early postnatal life is a critical period during which the brain undergoes significant development, and immune challenges, such as influenza, can potentially disrupt this process with long-lasting effects. This proposed study aims to identify the long-term neurobiological impacts of early postnatal influenza infection on synapse development, myelin plasticity, and glial dysregulation.